Regulation of cell function by mechanical properties of biopolymer networks and lipid bilayers

Project Summary:
Purchase of a Bio-Rad NGC Quest 10 FPLC system used to purify proteins required for
this R35 project to replace an older instrument that is no longer functional or repairable.

Public health relevance
Project Narrative Purification of large amounts of cytoskeletal and extracellular proteins are an integral part of the work of the parent R35 project. The protein purification system, more specifically the liquid chromatography instrument that is required for this protein purification in our laboratory, is over 15 years old and is no longer operational nor can it be repaired, since it has been discontinued by the manufacturer. We request funds for a similar instrument which is also compatible with the chromatography columns and other small items we currently have, so that we can optimally continue purification of required proteins.